COMPARATIVE STUDY OF OLCR IMAGES VS CONFOCAL IMAGES OF A RAT DORSAL SKIN

The broad, long term objective is the development of OLCR to characterize skin microcirculation at discrete spatial locations in either the superficial or deep dermis. Tomographic imaging of blood flow using OLCR will be compared to that obtained from conventional and 2-photon-excited confocal microscopy.